A-Z junction formation drives recognition of Alu RNAs by ADAR1 and supports viral infectivity and replication

Project Summary
Self and non-self RNA must be distinguished by the cell in order to avoid triggering the innate immune
response when not needed. In humans, self RNAs are edited by adenosine deaminase that acts on RNA
(ADAR1), which modifies adenosines to inosines. The vast majority of A-to-I editing events occur in primate-
specific Alu elements, which are the most prolific retrotransposon found within the human genome. Alu
elements have been shown to be the primary drivers of RIG-I, MDA-5, and TLR3 signaling suggesting that the
primary function of ADAR1-dependent editing of Alu elements is to suppress the immune response. Editing is
augmented upon infection by viruses primarily through the activity of the longer, interferon-induced, isoform of
ADAR1 (ADAR1p150), which is unique from the short isoform in that it has a N-terminal Z-RNA binding domain
(Zα) and that it is pro-viral. This suggests that the Z-RNA binding function of Zα plays a critical role in targeting
ADAR1p150 to Z-RNA-forming regions within Alu elements along with a nearby structurally homologous Zβ
domain, however, the RNA binding mechanisms and specificities of ADAR1p150 are poorly characterized. My
hypothesis is that the N-terminal Zα domain and the closely related Zβ domain augment A-to-I editing
by targeting ADAR1p150 to Z-RNA-forming regions within Alu elements during the interferon response.
This increased editing in-turn “blunts” the interferon response and allows many types of viruses to proliferate
unchallenged. In this proposal, I present a strategy which integrates structural biology, RNA-sequencing, and
biochemistry techniques to uncover specific Z-RNA-forming sequences within Alu elements and during
infection and answer basic questions about A-to-Z RNA transitions in Alu elements by the Zα and Zβ domains
of ADAR1p150. My specific aims are (Aim 1) to characterize the transition from A- to Z-RNA in Alu RNAs
through biochemical and structural techniques. I also plan (Aim 2) to investigate how the Z-RNA recognizing
ability of Zα and Zβ contributes to recognition and editing of Alu elements in vivo and how it correlates to West
Nile infection of HEK293T cells by RNA-sequencing techniques. Due to our lack of knowledge about the Z-
DNA/RNA binding domain of ADAR1, we have likely vastly overlooked the repertoire of RNA segments able to
adopt Z-conformations within the transcriptome. The results of my proposal will help to fill this gap in
knowledge, laying the foundations for further research on the importance of Z-RNA in biological processes and
help guide studies attempting to manipulate A-to-I editing as a tool for treating many types of diseases or
inhibit the pro-viral characteristics of ADAR1p150.

Public health relevance
PROJECT NARRATIVE RNA editing by adenosine deaminase that acts on RNA (ADAR1) helps control the cells inflammatory response by editing a unique RNA conformation, but at the cost of promoting viral infection and growth. The proposed research will gain a better understanding of how this unique conformation is recognized by ADAR1 at the molecular level. Using this knowledge, new treatment strategies can be designed in order to help fight viral infections.